Leptin in HIV associated vascular diseases

PROJECT SUMMARY
Combination antiretroviral therapy (cART) has been remarkably successful in combating opportunistic AIDS-
related diseases and increasing life expectancy. However, cART has unexpectedly shifted the spectrum of
disease burden towards an acceleration of cardiovascular diseases (CVD), including atherosclerosis, which is
now the leading cause of mortality in HIV patients. Strikingly, contemporary cART regimens have also induced
a drastic switch in the metabolic phenotype of HIV patients from a loss (lipoatrophy) to a pronounced gain in
adiposity. Yet, increased adiposity does not further augment CVD risk in contemporary HIV patients, creating an
obesity paradox in HIV-cART. A critical barrier to the prevention of CVD in HIV patients is our lack of
understanding of the mechanisms whereby HIV and cART regulate adiposity and atherogenesis, and the role of
adiposity in HIV-cART-associated vascular diseases. Herein, we provide exciting new preliminary data indicating
that HIV viral infection promotes atherosclerosis in mice. We show that viral infection and lipoatrophy induce
endothelial dysfunction by reducing leptin levels and leptin signaling in the vasculature. We find elevated
expression of the oxidant generating enzyme Nox1 in blood vessels and show that ROS scavenging with tempol,
or pharmacological inhibition of Nox1, restores endothelial function in our rodent models of HIV and lipoatrophy.
In parallel, we report decreased leptin signaling and increased vascular inflammation in aortic sections from
human HIV patients. Remarkably, chronic leptin treatment robustly improves endothelium-dependent relaxation
in rodent models of HIV and lipoatrophy. Moreover, leptin markedly reduces Nox1 expression in aortae and
blunts expression of pro-inflammation mediators. Strikingly, selective deletion of the leptin receptor in endothelial
cells impairs endothelial function via a Nox1-dependent mechanism. Lastly, we show that viral infection
increases TNFα which is a known positive regulator of energy expenditure. We also report that viral infection
prevents diet-induced adipose tissue expansion, while the contemporary cART regimen Odefsey markedly
increases body weight without inducing endothelial dysfunction in wild-type mice. Taken together, these exciting
and novel findings inform the core hypothesis of this proposal: HIV promotes atherosclerosis by disrupting
endothelial leptin signaling and augmenting Nox1 expression, which is opposed by contemporary cART
regimens that preserve adiposity and leptin levels. We will test this hypothesis in the following specific aims: (1)
Activation of endothelial leptin signaling protects against endothelial dysfunction in HIV-cART; (2) Contemporary
cART regimens prevent the development of atherosclerosis in HIV mice via adipose-leptin mediated
improvement in endothelial function and reduction in vascular immune cell infiltration; and (3) HIV and cART
regulate body weight via TNFα-mediated control of energy expenditure. The expectation is to identify the
molecular mechanisms whereby HIV and cART regulate adiposity and atherogenesis to identify new therapeutic
avenue for the prevention and treatment of CVD- associated with HIV.

Public health relevance
PROJECT NARRATIVE Atherosclerosis-associated cardiovascular diseases are currently the leading cause of death in HIV patients under antiretroviral therapy. However, the molecular mechanisms predisposing HIV+ patients to atherosclerosis remain poorly defined and unstudied. The proposed study will combine the use of novel genetically engineered animal models with discarded human samples, cultured endothelial cells and pharmacological approaches to decipher the respective contribution of viral infection and antiretroviral therapy to the formation of atherosclerotic lesions.